Understanding the variability in nonsense-mediated RNA decay

PROJECT SUMMARY
Predicting functional consequences of genomic variation remains the biggest barrier to precision
medicine. While nonsense variants are considered the best understood of all genetic variants, our
work has revealed significant gaps in our knowledge base for their functional interpretation. My
group studies how variability in mRNA surveillance impacts the functional consequence of human
genetic variants. Protein-truncating genetic variants often cause loss of gene function because
their encoding transcripts are subject to degradation by an RNA quality control process called
nonsense-mediated RNA decay (NMD). NMD senses transcripts with a premature stop codon
and triggers their degradation to prevent the production of truncated proteins. However, the
efficiency with which NMD acts on a target transcript is variable across genes, tissues, and even
individuals. We have shown that non-canonical translation events such as stop codon
readthrough and translation reinitiation can cause NMD evasion by a nonsense-containing
transcript, though the rules governing such events are unknown. My research program builds on
these discoveries to systematically investigate factors that cause variable NMD efficiency.
Specifically, we combine massively parallel reporter assays with targeted gene editing to identify
and validate sequence features that permit NMD escape. Through this work, we aspire to build
new rules for the functional classification of variants and use such rubrics to build more accurate
and predictive models for phenotypic consequence of nonsense variants. Such a model will allow
us to identify variants that are likely to cause disease and to develop novel therapeutic approaches
to counter genetic disorders.

Public health relevance
PROJECT NARRATIVE All cells have surveillance mechanisms to detect and degrade aberrant RNAs carrying nonsense mutations. The goal of my research program is to characterize the factors that induce variability in RNA surveillance. Better understanding of this variation will improve the clinical interpretation of genetic variants, and may help identify novel therapeutic approaches to counter genetic disorders.